Circadian Neurocircuit Mechanism in Metabolism and Time Restricted Feeding

PROJECT SUMMARY
The circadian rhythm is an intrinsic 24-hour cycle which regulates the sleep/wake cycle, energy expenditure and
storage, and body temperature in anticipation of the needs of the day. Disruption of the circadian cycle can occur
through jetlag, sleep loss, shiftwork, feeding at the wrong time of day, and with experimental genetics. The
dysregulation of the circadian rhythm is associated with insulin resistance, susceptibility to diet-induced obesity,
and decreased ability to regulate body temperature through mechanisms that remain incompletely understood.
Recent research from our lab has demonstrated that feeding animals a high-fat diet (HFD) during the inactive
period of the 24-hour cycle exacerbates diet-induced obesity and metabolic syndrome through reduced futile
creatine cycling in thermogenic brown adipose tissue (BAT). Further, our lab has identified a neural circuit from
arginine vasopressin-expressing neurons of the suprachiasmatic nucleus (SCNAVP) to neurons of the
dorsomedial hypothalamus (DMH) as an important mediator of time-of-day appropriate energy expenditure:
chemogenetically activating the normally silent SCNAVP → DMH circuit during the active period of mice induces
a significant decrease in thermogenesis and body temperature during the active period. Combined with recent
research indicating that sympathetic adrenergic signaling within brown adipose tissue exerts control over
creatine-mediated thermogenesis, I seek to unravel the relationship between time-restricted feeding and SCNAVP
→ DMH in the control of thermogenesis. The interaction between feeding time and the circadian clock in
regulating brown adipose thermogenesis, remain an open question. In this proposal, I aim to test the novel
hypotheses that the circadian clock integrates feeding time and brown adipose thermogenesis through
rhythmic activity within the SCNAVP → DMH circuit (i), and that both SCNAVP → DMH signaling and meal
time exert molecular control over thermogenesis through the brain-adipose axis (ii). In Aim 1, I will
determine the roles of feeding time and the molecular clock in SCNAVP → DMH control of thermogenesis. I will
evaluate the role of active-period time-restricted chow and HFD feeding after mistimed chemogentic activation,
as well as genetic ablation of the molecular clock, in the SCNAVP → DMH circuit to determine how meal timing
affects the neural-mediated thermogenesis in absence of the molecular rhythm. In Aim 2, I will test the hypothesis
that both SCNAVP → DMH signaling and feeding time regulate peripheral thermogenesis in BAT. I will determine
the mechanism by which the activity of the SCNAVP → DMH circuit regulates diet-induced thermogenesis via cold
challenge and brown fat molecular function. I will also examine the effect of time-restricted feeding on BAT
thermogenesis in response to autonomic catecholamine signaling from the sympathetic nervous system. The
work presented in this proposal will dissect the contributions of meal timing and the molecular circadian
clock to the function of a neural circuit and its peripheral projections in regulating diet-induced
thermogenesis and metabolic health.

Public health relevance
PROJECT NARRATIVE The circadian rhythm coordinates diurnal regulation of feeding, energy expenditure, and the sleep/wake cycle, and disruption of this rhythm through shiftwork, jetlag, or sleep disorder is acutely linked with metabolic syndrome and obesity. Previous work from our lab has identified a hypothalamus-originating neural circuit that is important in the control of energy expenditure and body temperature, and more recent work from our lab has identified that time-restricted feeding to the active period promotes metabolic health via adipocyte thermogenesis; however, the role of meal timing in this circuit’s, and its peripheral targets’, control of diet-induced thermogenesis remains unknown. Using transgenic mouse models and chemogenetic circuit activation, I propose to study the contributions of feeding time and the central circadian clock to neural control of thermogenesis, towards the ultimate goal of mitigating obesity and metabolic disease.